HNF4 Isoforms in Physiology and Disease

DESCRIPTION (provided by applicant): The ying/yang relationship of differentiation versus proliferation is a fundamental tenet in the development of multicellular organisms, as well as the basis for cancer. Transcription factors (TFs), such as nuclear receptors (NRs), regulate the genes responsible for carrying out these cellular processes. HNF4α is a highly conserved member of the NR superfamily of ligand dependent TFs. During the past 20+ years, HNF4α has been well characterized for its role in early development, liver differentiation and an inherited form of diabetes (MODY1). More recently, a role for HNF4α has emerged in the intestine/colon and several links to cancer have been reported. Intriguingly, the role for HNF4α in cancer seems to depend on the particular isoform of HNF4α: there are nine isoforms driven by two alternative promoters, P1 and P2. Here, we propose to follow up on the results from the previous round of funding in which we identified the mechanism responsible for differential regulation of the P1- and P2-driven HNF4α isoforms in human colon cancer. That mechanism involves the oncogene Src tyrosine kinase and is impacted by single nucleotide polymorphisms (SNPs) in the HNF4α gene. We will pursue the following three Specific Aims: 1) Determine the role of the P1- versus P2- HNF4α isoforms in the colon by using mouse models, human culture models and human tissue analysis; 2) Determine the role of P2- HNF4α in liver cancer and development by using mouse models and cutting edge -omic approaches to decipher the molecular basis for the differences in the isoforms; and 3) Elucidate the effects of the Src tyrosine kinase pathway on HNF4α using mouse and human models. The proposed experiments will provide invaluable insights not just into the molecular mechanisms of cancer but also into the dichotomy between the differentiation and proliferation and molecular mechanisms of nuclear receptor action. They will generate results that could be of use in the clinic to help properly diagnose and treat liver and colon cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: While cancer death rates decreased in the U.S between 2004 and 2009, certain cancers remain very prevalent and cause large numbers of deaths. Others cancers have increased rates of incidence and yet the survival rates remain very low. For example, colorectal cancer is the third most deadly cancer in the U.S., claiming >50,000 deaths every year. And, the incidence of liver cancer, which has the second lowest survival rate (~15%), is actually increasing. Major risk factors for liver cancer are viral infections that cause hepatitis (e.g., HBV and HCV) as well as the metabolic syndrome that is associated with obesity and diabetes. Colon cancer is also directly impacted by diet. Obesity and diabetes have increased in the U.S. and worldwide to epidemic proportions with more than 55% of adult Americans classified as obese. This proposal examines the role of a gene, HNF4α, in both colon and liver in normal tissue and cancer. The ultimate goal is a better understanding of how these cancers progress so that we can eventually develop better methods of treating them. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Despite remarkable advances in cancer research in the past several decades, cancer remains a major health issue in the U.S. and is an increasing problem worldwide. While the incidence and death rates from certain cancers have been steadily declining in recent years, the rates of other cancers remain high and some are even increasing. Two such cancers are colorectal (CRC) and hepatocellular cancer (HCC). Both of these cancers are potentially linked to diet, obesity and the metabolic syndrome. Due to the epidemic rise in obesity we can anticipate that cancers such as CRC and HCC may become even more prevalent than they are now. Therefore, there is an urgent need to better understand the mechanisms responsible for colon and liver cancer so that we can better predict susceptibility, more easily diagnose and more effectively treat patients. Nuclear receptors (NRs) are a superfamily of ligand-dependent TFs that play well described roles in both the promotion and the inhibition of cancer. Many NRs also respond to components in the diet, acting as environmental sensors (e.g., PPARs, FXR, CAR/PXR). Hepatocyte nuclear factor 4α (HNF4α, NR2A1) is one such NR. HNF4α is well known for its role as a master regulator of liver-specific gene expression and for being mutated in an inherited form of type 2 diabetes, MODY1. We recently identified the endogenous HNF4α ligand as the essential fatty acid linoleic acid, although its role in HNF4α function is not yet completely understood. There is an emerging role for HNF4α in the gut and in cancer. Recent reports indicate that the major isoform of HNF4α in the adult liver (P1-HNF4α) is not only down regulated in HCC and CRC, but that it can also act as a tumor suppressor, at least in HCC. What is less clear is the role of the other major HNF4α isoform that is expressed in fetal (but not normal adult) liver, as well as the colon. This isoform, referred to as P2-HNF4α, is generated from an alternative promoter. It is not down regulated in CRC and is in fact aberrantly upregulated in some liver cancer. Interestingly, P1- and P2-HNF4α differ by only 16-30 amino acids at their N-termini: the DNA and ligand binding domains are identical. We recently elucidated one mechanism responsible for the dysregulation of the HNF4α isoforms in human CRC that involves the oncogene Src, a tyrosine kinase activated in both CRC and HCC. However, what we do not yet know is exactly what roles the different HNF4α isoforms play in normal liver and colon, or in cancer. We do not know if the disruption of the balance of the HNF4α isoforms per se leads to cancer, and if so by what mechanism (Fig.1). Aim 1. Determine the role of the P1- and P2-HNF4α isoforms in the colon. Fig.1. Central focus of proposal. The adult colon expresses both P1- and P2-HNF4α but the role of the different isoforms is not known in either normal tissue or cancer. We will address these issues using a variety of systems: HNF4α isoform-specific mice generated using an exon swap strategy; human colon cancer and immortalized cell lines; isolated human (and mouse) colonic crypts and organoids derived from human embryonic stem cells. The expression of P1-HNF4α and P2-HNF4α will be experimentally manipulated and a variety of properties related to cancer will be assayed. SNPs in HNF4α that increase its susceptibility to Src will be examined in 500 human CRC patients. Aim 2. Determine the role of the P2-HNF4α isoform in liver. The effect of P2-HNF4α on the liver will be examined by identifying the target genes (protein coding and noncoding) that are unique to P2-HNF4α using the isoform-specific mice; the mechanism responsible will be investigated using protein binding microarrays (PBMs) to characterize DNA binding specificity and proteomics to identify interacting proteins. Novel transcripts as well as proteins will be identified in discovery-based experiments. Finally, the impact of P2-HNF4α on liver cancer will be investigated in mouse models of HCC. Aim 3. Elucidate the effects of the Src tyrosine kinase pathway on HNF4α. A variety of agents that lead to HCC, such as cytokines and hepatitis B virus (HBV), are also known to activate the Src pathway. Our preliminary data show a rapid effect of IL-6 on P1-HNF4α in the liver (~30 min). We will determine whether this effect is via Src and the consequences of the observed decreased in nuclear P1- HNF4α. We also have preliminary results showing that the co-activator PGC1α inhibits the negative effects of Src on P1-HNF4α; these will be explored in greater detail. Finally, we present preliminary results suggesting that HNF4α is dysregulated in human and mouse HBV. We will investigate further whether the Src-HNF4α pathway is activated in HBV-mediated liver cancer using human tissue samples and a mouse model of HBV. This proposal will use innovative tools to investigate the roles of HNF4α isoforms and a novel pathway (Src- HNF4α) in physiology and disease. In so doing, it will provide novel insight into NR mechanism of action and open up new avenues of research for predicting, diagnosing and treating two deadly diseases - HCC and CRC.